Role of Microglial Hur in promoting neuroinflammation and ALS disease progression

Amyotrophic lateral sclerosis (ALS) is a degenerative disease of motor neurons that leads to progressive
weakness and death. There is no effective treatment, leaving the patient (and family) burdened with an
overwhelming emotional, physical and monetary fallout as the disease progresses. The physician can provide
some symptomatic relief, but there is a deep sense of frustration in not being able to treat the disease,
underscoring a strong need to identify new treatments. Veterans of foreign wars have a significantly higher
incidence of ALS than the civilian population, and thus investigations into disease mechanisms and novel
therapeutic pathways, such as the one proposed here, are of direct relevance to the VA mission.The ever
growing list of genes linked to ALS implicates a wide range of molecular pathways in disease initiation.
Neuroinflammation, however, is a common downstream element in ALS that, independent of the disease
initiating factor, can modulate disease progression. Microglia are a major component of neuroinflammation and
play dual roles in ALS: on the one hand delaying clinical onset and progression early in the disease and on the
other hand accelerating disease progression in later stages. The diversity of these roles reflects the broad and
dynamic molecular repertoire of the microglial cell. Understanding the determinants of this repertoire is critical
for opening up new therapeutic approaches. In our preliminary data and recent publication, we have identified
the RNA binding protein HuR as a major promoter of inflammatory cytokine and chemokine production in
microglia and a suppressor of anti-inflammatory cytokines. Through the regulation of downstream targets, we
found that HuR drives many cellular properties of microglial activation including migration, invasion and the
chemoattraction of other immune cells. This background forms the basis of our hypothesis that HuR plays a
pivotal role in ALS by promoting the molecular underpinnings of pro-inflammatory activation in microglia and
suppressing the molecular program that promotes an anti-inflammatory, disease delaying phenotype. We
propose three specific aims to address this hypothesis: 1) determine the molecular mechanism of pro-
inflammatory cytokine attenuation and anti-inflammatory cytokine augmentation in wild-type and ALS-
associated microglia after HuR knockout, 2) characterize the impact of HuR knockout on wild-type and ALS-
associated microglial activation, migration/invasion in response to inflammatory signals and on chemoattraction
of other immune cells, and 3) characterize the impact of HuR knockout in microglia on ALS onset and
progression in the mutant SOD1 mouse. We recently developed a mouse model in which HuR is genetically
deleted from microglia and this will greatly facilitate the completion of these aims. The long term objective of
this proposal is to characterize the role of post-transcriptional gene regulation in governing the molecular and
cellular phenotype of glia and the impact on ALS. The innovation of this proposal is its investigation of post-
transcriptional regulation as a novel pathway in neuroinflammation and a proof-of-principle investigation of HuR
as a therapeutic target in ALS. The significance of this application extends beyond ALS as microglia and
neuroinflammation play critical roles in modulating other CNS disorders including Alzheimer's, Parkinson's,
multiple sclerosis ,spinal cord injury and stroke.

Public health relevance
Amyotrophic lateral sclerosis is a relentless disease of motor neurons that leads to progressive paralysis of the muscles and ultimately death. There is a significantly increased incidence of this disease in our veterans of foreign wars, and treatment options are limited and with only modest effect. Initiation of ALS and its progression is markedly influenced by neuroinflammation that is triggered by immune cells in the central nervous system. This proposal will address the molecular mechanisms of neuroinflammation in ALS by focusing on microglia which are key contributors to the immune response in ALS. This work will identify novel pathways that can be targeted for new therapies in this devastating disease.